Spatial proteomics using highly parallel fluorescence hyperspectral and lifetime imaging

Abstract
Multiplexed spatial profiling of protein markers in cells and tissues is critical to basic research and clinical
applications. Unfortunately, we currently lack tools that can rapidly and routinely profile a large number of proteins
in situ in large tissues with subcellular resolution in a time and cost-effective fashion. Existing tools for in situ
protein analysis including immunohistochemistry and immunofluorescence suffer from low multiplexing because
of limited separation of spectral channels. Recent single-cell sequencing methods lack the critical spatial context
needed to understand complex heterogeneous samples. Other spatial proteomics methods that are based on
serial labeling and imaging, indirect indexed mass spectrometry or sequencing are complicated, time-consuming
and expensive. This proposed project will develop a new spatial proteomics technology termed as Phasor S-
FLIM that enables direct, simultaneous, high-plex spatial profiling of protein markers in large and thick tissues
with just one-round of staining and imaging. Our Phasor S-FLIM system, for the first time, allows true parallel,
simultaneous lifetime and spectral detection with phasor analysis to obtain fast, unbiased, high-precision lifetime
and spectral data that can be processed in real time. In the proposed work, we will adapt and further develop
Phasor S-FLIM for high-plex spatial proteomics applications, including (a) implementation of Pulsed Interleaved
Excitation (PIE) dual excitation with 2-photon lasers and sensitive multi-channel GaAsP PMT arrays, enabling
exciting and detecting a broad range of fluorophores (Aim 1), (b) development of a novel fluorophore-quencher
labeling strategy to generate a large repertoire of probes with orthogonal lifetime and spectrum signatures for
high-plex target encoding (Aim 2), and (c) characterization, validation and benchmarking of Phasor S-FLIM for
multiplexed spatial protein analysis using broadly relevant biological and clinical tissue models (Aim 3). Once
developed, we expect the Phasor S-FLIM can detect at least 30 different protein targets through direct, one
round of staining and imaging, in thick (>0.5 mm) tissues, with subcellular resolution (200 nm), and in high
imaging throughput (1 x 1 mm2 plane in <15 min), which is currently not possible with existing methods. Upon
successful completion of the proposed work, we will have established a working prototype ready to quickly serve
the scientific community to address a broad range of biological and clinical questions that are previously
impossible or impractical. Our technology can potentially shift current practice in interrogating protein and cellular
processes as well as the complexity and systems in biology and disease with high resolution, throughput and
scale.

Public health relevance
Project Narrative This project will develop a new spatial proteomics technology for high-plex, 3D spatial mapping of protein markers and single cells in large tissues using highly parallel fluorescence spectrum and lifetime imaging. This tool will broadly enable us to study how the spatiotemporal regulation of protein expression, cell function and their cooperation mediates organ development, tissue homeostasis, and disease formation and to develop personalized diagnostics and treatments.